A biomolecular purification system for biophysical studies of protein synthesis

Abstract Our research group seeks to understand the assembly and mechanism of eukaryotic protein synthesis machinery in order to identify critical steps that contribute to the molecular mechanisms that drive and regulate the translation of mRNA into proteins. To achieve this we have developed experimental methods that combine (i) reconstitution of in vitro translation systems from highly purified components; (ii) fluorescent site-specific labelling of these components and validation that the labeled components are active; (iii) biophysical assays to determine the binding affinity and kinetics of assembly of these complexes and (iv) expression of reporter mRNA to determine the functional effects of these protein-nucleic acid interactions. Specifically we are examining the roles of eIF4G1 and DAP5 in eIF4E-independent translation of mRNAs expressed under stress conditions. We have developed a unique set of assays and combined our expertise with single molecule fluorescent measurements done in Prof. Ruben Gonzalez' lab to provide new insights into the mechanism and regulation of mRNA expressed under stress conditions. We are requesting an AKTA purification system to obtain high quality samples necessary for our experiments.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT A number of diseases for which there is an urgent need to identify new and better molecular targets for treatment, including breast cancer, diabetic retinopathy and neurological disorders, are correlated with and, in some cases, caused by dysregulation of protein synthesis, or translation. Consequently, understanding how healthy cells, which employ a cap-dependent mechanism of translation, switch a subset of mRNAs to a cap- independent mechanism of translation that is associated with these diseases could provide an avenue for identifying such targets. Our proposed studies, which are aimed at elucidating the mechanism of this switch, therefore have the potential to identify new therapeutic targets for treating diseases in which the switch from cap-dependent to cap-independent translation plays a significant role.